National Institute on Drug Abuse Clinical Trial Network: New England Consortium Node

PROJECT SUMMARY
In recent years there has been a marked surge in opioid overdose deaths across Black and Latino populations.
Addiction treatment, which includes medications for opioid use disorder (MOUD) such as buprenorphine,
decreases fatal opioid overdoses. Yet Black and Latino individuals face substantial disparities in access to
MOUD and addiction treatment. The emergency department (ED) represents an emerging setting to initiate
MOUD and provide linkage to ongoing addiction treatment to Black and Latino individuals with untreated opioid
use disorder (OUD). However, little is known about the barriers and facilitators that Black and Latino individuals
encounter to engage in addiction treatment subsequent to an ED visit. Moreover, less is known about the
differences in ED presentation for opioid overdose, polysubstance use, major depressive disorder, and stigma
within these populations. Filling these knowledge gaps are important because opioid overdose, polysubstance
use, major depressive disorder, and stigma have each been linked to worse treatment outcomes. Further,
eliciting barriers and facilitators can inform future ED-based interventions to enhance engagement in addiction
treatment among Black and Latino individuals with untreated OUD. The goal of this proposal is to evaluate
disparities in access to addiction treatment and elicit potential targets for ED-based interventions that enhance
engagement in addiction treatment among Black and Latino populations. The specific aims are to: 1) conduct
a qualitative study focusing on patterns of barriers and facilitators to engaging in addiction treatment among
Black, Latino, and non-Latino White patients receiving ED-initiated buprenorphine treatment with a referral for
continuation of OUD treatment outside of the ED and 2) evaluate differences among Black, Latino, and non-
Latino White ED patients with untreated OUD on factors previously identified as predictors of worse treatment
outcome, including opioid overdose, polysubstance use, major depressive disorder, and stigma, using
supplemental analyses of data collected in CTN 0099. To accomplish this, we will conduct both semi-structured
individual interviews of Black, Latino, and non-Latino White participants enrolled in CTN 0099 after they have
completed their final 30-day assessments and supplemental analyses from data collected in CTN 0099. Study
findings will inform the development of an ED-based intervention that enhances engagement in addiction
treatment among Black and Latino populations subsequent to ED visit.

Public health relevance
PROJECT NARRATIVE Black and Latino individuals with untreated opioid use disorder face significant disparities in access to ongoing addiction treatment after an emergency department visit. The goal of this proposal is to elicit potential targets for emergency department-based interventions that improve engagement in addiction treatment among Black and Latino individuals.